Breast Cancer Patterns of Care and Outcomes by Diabetes Status Among American Indians in the Cherokee Nation

The Cherokee- Native American Research Center for Health (C-NARCH) continues the productive research training and capacity-building partnership between the University of Oklahoma Health Sciences Center (OUHSC) and the Cherokee Nation. (C-NARCH). This specific proposal is a product of intense consultation between the Cherokee Nation and OUHSC, which has resulted in the final structure of Cherokee-NARCH and the final roster of projects. Initial conversations, including conferences and in-person meetings, between the key troibal and university stakeholders focused on the identification of priorities for the Cherokee Nation. The group agreed to use its Community-Campus Advisory Counsel (CCAC) to establish the selection criteria for the highest priority projects. These were required to have the following elements, in order of priority: acceptable to the Cherokee Nation and focused on the priority area for tribal leadership, relevant to health disparities in the American Indian population in our setting, and consistent with tribal research agendas and priorities. Selected projects had to be judged as being scientifically sound and potentially NIH-fundable and equally importantly, have the potential to build trust. This strategy allowed Cherokee Nation to exercise its sovereign right to participate in capacity development, faculty development and research projects deemed most relevant by the tribe. The plan set forth in this application will advance these priorities through five interconnected aims: 1) To develop a collaborative and productive partnership, grounded in a foundation of mutual trust and respect, for prioritizing and advancing research involving the Cherokee Nation, OUHSC; and other tribal partners in our state; 2)To establish robust research-oriented, capacity building and faculty enhancement programs that will establish a cadre of American Indian/Alaska Native (AI/AN) scientists and health professionals who are meaningfully engaged in reducing tribal health disparities; 3) To jointly conduct studies aimed at elucidating and remedying AI/AN disparities; 4) To conduct collaborative tribal-academic studies aimed at elucidating and remedying AI/AN health disparities; and 5) To coordinate Cherokee NARCH activities with those of our other NIH awards to identify synergies between projects.